Discovery of single-domain antibodies targeting CD206

During this period, the team performed phage panning using multiple strategies including in the presence or absence of RP-182. This conformational panning approach was aimed at finding single-domain antibodies capable of inducing or locking CD206 in the closed conformation. This is important since the closed conformation has been associated with M2 to M1 phenotypic transition. The team identified single-domain antibodies with strong CD206 binding activity. These antibodies have been produced and validated in downstream assay for their ability to reprogram macrophage activity. The next steps include the identification of single-domain antibodies against CD47 and PD-L1 for generation of a trivalent antibody.